Developmental Therapeutics Research Program

DEVELOPMENTAL THERAPEUTICS RESEARCH PROGRAM
PROGRAM CODE: DT
PROJECT SUMMARY/ABSTRACT
The highly collaborative, transdisciplinary Developmental Therapeutics (DT) Research Program is a critical
translational innovation hub for Yale Cancer Center (YCC), bridging drug discovery and experimental
therapeutics to translate preclinical discoveries to patients, while returning clinical advances to the bench for
refinement. To achieve this mission, DT capitalizes on the science of all six YCC Research Programs. DT
assembles a critical mass of laboratory and clinical investigators who command expertise from basic and
translational science to science-driven clinical trial design and implementation. DT members have the proven
ability to translate findings into development, evaluation, and approval of new therapies. The breadth of expertise
in DT allows its members collectively to serve as a translational touchpoint for all YCC Programs. DT’s most
important focus is the transition from identification of a novel therapeutic target or strategy, through development
of a drug candidate, to early-phase clinical trials and correlative science. Our goal is to translate inventive YCC
science in directions informed by YCC’s strategic priorities accompanied by bidirectional community interaction.
We pursue three specific aims: 1) To translate basic discoveries into clinical candidates and strategies, with a
particular focus on historically undruggable targets such as p53, RAS, MYC, and immunotherapy-resistant
cancers; 2) To conduct rationally designed trials of novel anticancer therapies and hypothesis-driven
combinations, including immunotherapy with conventional targeted or cytotoxic therapies; and 3) To rapidly
validate new anticancer therapies by incorporating molecular selection. YCC promotes transdisciplinary
collaboration within DT and enhances cancer focus via inter- and intra-programmatic meetings, recruitment,
space, pilot funding, support for multi-investigator grant applications, mentorship, and Shared Resource
improvements. YCC members are intimately involved in pivotal advances in cancer medicine, including
molecular profiling, innovations in chemical biology, and immunotherapy. We leverage scientific breadth and
exceptional early-phase clinical research capacity to overcome barriers to progress in cancer therapeutics. The
Early Phase Clinical Trials Network UM1, Hybrid Decentralization Project, P50 Lung, Head and Neck, and Skin
SPOREs and Lead Academic Participating Site grant from the NCI National Clinical Trials Network add resources
and drive DT translational efforts. DT is also focused on increasing engagement with underserved communities.
DT has 59 members from 16 departments across the Schools of Medicine, Public Health, Faculty of Arts and
Sciences, and Engineering & Applied Sciences. Total cancer-related funding is $23.4M (direct costs). This
includes $7.9M in peer-reviewed funding, of which $4.4M is from NCI, representing a 26% increase in NCI
funding since the last renewal. DT members serve as trainers on YCC training grants, mentor trainees and junior
faculty, and work to advance diversity at YCC. DT members published 806 papers during this award period, 32%
in high impact journals, with inter-programmatic (38%) and intra-programmatic (22%) publications.

Public health relevance
DEVELOPMENTAL THERAPEUTICS RESEARCH PROGRAM – NARRATIVE Not applicable.